Impact of Clonal Hematopoiesis of Indeterminate Potential (CHIP) on tumor microenvironment and clinical outcomes in triple negative breast cancer

PROJECT SUMMARY
With age and exposure to genotoxic stress, tissues throughout the body acquire somatic mutations. In the blood
and bone marrow, somatic mutations are frequently found in leukemia-associated genes in subsets of
hematopoietic cells even in the absence of hematologic cancer. This phenomenon has been termed Clonal
Hematopoiesis of Indeterminate Potential (CHIP) because while many people with such mutations will have no
known clinical impact, the presence of these clonal populations is associated with increased risk or poor
outcomes in diseases ranging from hematologic malignancy and cardiovascular disease to osteoporosis and
COVID-19. While CHIP affects at least 10% of people over age 70, it impacts as many as 25% of patients with
solid tumors, likely driven by the genotoxic stress of chemotherapy and radiation. Recent studies have shown
that CHIP may result in aberrant inflammatory programming, particularly in myeloid lineages, and that immune
cells with CHIP mutations can infiltrate the tumor microenvironment. Moreover, research suggests that CHIP
may be associated with worse overall survival among solid tumor patients. Given the importance of the tumor
immune microenvironment and the increased burden of CHIP in these populations, there is a fundamental need
to examine the interplay between CHIP and solid malignancies and to explore how to clinically manage solid
tumor patients with CHIP. This proposal seeks to use clinical sequencing data, patient samples, mouse models,
and ex vivo experiments to determine the impact of CHIP on solid tumor outcomes and immune
microenvironment using triple negative breast cancer (TNBC) as a model system. TNBC is an aggressive
subtype of breast cancer that lacks expression of estrogen receptor, progesterone receptor, and HER2.
Importantly, TNBC often has a prominent immune cell infiltrate that is prognostic: the presence of lymphocytes
is associated with favorable outcomes, while the presence of tumor-associated macrophages is a negative
prognostic indicator. Aim 1 will leverage multiple large biobanks, prospectively collected patient specimens, and
a novel mouse model to define CHIP as a prognostic biomarker for TNBC outcomes, including overall survival
and response to therapy. Aim 2 will harness both patient-derived immune cells and mouse models to determine
how myeloid cells with CHIP mutations interact with TNBC cells. Techniques to be utilized include
histopathology, flow cytometry and immunophenotyping, gene expression analysis, and functional immune cell
assays. Completion of this work will provide a comprehensive training vehicle for this fellowship and will
simultaneously yield new insights into clinical management of solid tumor patients with CHIP, suggesting novel
therapeutic approaches for these patients. These studies will also provide a greater understanding of how
dysregulated myeloid cell signaling in CHIP clones leads to differential interaction in the tumor microenvironment.

Public health relevance
PROJECT NARRATIVE Clonal Hematopoiesis of Indeterminate Potential (CHIP), a common clinical entity in which people without clinical hematologic abnormalities have somatic leukemia-associated mutations in their blood and bone marrow, is increasingly being recognized as a dysregulated inflammatory process that is more prevalent among patients with solid tumors. Interrogating the interplay between CHIP and solid tumors via murine models and ex vivo experiments, using triple negative breast cancer as a model system, will enhance understanding of the tumor immune microenvironment and define potential new therapeutic targets and management strategies. Harnessing large clinical biobanks and prospectively collected clinical specimens will further provide translational insight into the use of CHIP as a prognostic biomarker for patients with solid tumors.